Povidone-iodine to Stop Access-related Infections and Transmission of Staphylococcus aureus (PAINTS)

Abstract
Background: The long-term objective of the “Povidone-iodine to stop Access related INfections and
Transmission of Staphylococcus aureus (PAINTS)” proposal is to decrease rates of healthcare-
associated infections that occur outside of the hospital (i.e., community-onset infections). Recent data
from the Centers for Disease Control and Prevention (CDC) demonstrated that 83% of methicillin-
resistant Staphylococcus aureus (MRSA) bloodstream infections are community-onset. Hemodialysis
patients are at high-risk for community-onset bloodstream infections, particularly S. aureus access-
related bloodstream infections (ARBSI). These infections cause increased morbidity and mortality.
Nasal povidone-iodine decolonization is a novel intervention that can potentially prevent S. aureus
ARBSI in this patient population. Specific Aims: Aim 1: Assess whether nasal povidone-iodine
decolonization reduces infections among hemodialysis patients using a multicenter, stepped-wedge
cluster randomized trial. Primary outcome: S. aureus ARBSI. Secondary outcomes: Other S. aureus
dialysis-associated infections as defined by the CDC National Healthcare Safety Network, ARBSI
caused by pathogens other than S. aureus, all dialysis-associated infections caused by all pathogens,
and S. aureus colonization and transmission. Aim 2: Evaluate patient satisfaction with nasal povidone-
iodine decolonization, assess its role in patient activation, and assess barriers and facilitators to
implementation using patient surveys. Aim 3: Examine healthcare worker satisfaction with
implementation of nasal povidone-iodine decolonization and assess barriers and facilitators to the
process via qualitative interviews and site visits. Research Design: We aim to perform a randomized
stepped wedge study among 16 hemodialysis units affiliated with 5 geographically diverse healthcare
centers to evaluate whether nasal povidone-iodine will reduce rates of S. aureus ARBSI among
hemodialysis patients. These hemodialysis units represent both rural and inner-city patients who
receive chronic care (AHRQ priority populations). We will survey all patients and qualitatively interview
healthcare workers to assess the acceptability and feasibility of this intervention, as well as barriers and
facilitators to implementation. We will test patients' noses for S. aureus colonization to determine
whether nasal povidone-iodine decreases S. aureus colonization and S. aureus transmission. The sites
that will participate in this study (University of Iowa, University of Illinois, University of Pennsylvania,
Washington University, Emory Healthcare) have a good history of collaboration. Relevance: This study
will help AHRQ address its goal to “build the evidence for fighting antibiotic resistance in the ambulatory
setting,” and help meet the National Action Plan to Prevent Healthcare-Associated Infections
recommendation that hemodialysis centers aim to improve ARBSI rates.

Public health relevance
Project Narrative Hemodialysis patients are at high-risk for infections, specifically Staphylococcus aureus infections. We propose to 1) implement a novel intervention (nasal povidone-iodine prior to each dialysis session) to prevent S. aureus infections using a randomized stepped-wedge cluster randomized trial, and 2) evaluate the feasibility and acceptability of this intervention. If successful, this intervention can be used among hemodialysis patients, and evaluated in other high-risk patient populations to prevent S. aureus infections.